Targeting pyrimidine biosynthesis in pancreatic ductal adenocarcinoma

Project Summary
Pancreatic ductal adenocarcinoma (PDAC) is almost universally lethal and is projected to become the
second-leading cause of cancer related deaths in the US by 2030. Conventional (genotoxic) chemotherapy
approaches that make up the current standard of care are mostly ineffective and prolong survival of advanced
PDAC patients by less than one year on average. Similarly, small molecule drugs targeting aberrantly activated
oncogenic signaling pathways have shown disappointing clinical results and accordingly have failed to gain
FDA approval for PDAC. An alternative strategy to these two approaches is to exploit metabolic dependencies
that are unique to malignant cells by virtue of their deranged cellular metabolism.
While there are well-characterized resistance mechanisms to genotoxic and targeted therapies, deprivation
of certain nutrients critical for proliferation of malignant cells appears to be an insurmountable barrier for cancer
progression. However, cells have redundant means of acquiring these critical nutrients, and so inhibition of a
single metabolic enzyme is generally not sufficient to deny them to cancer cells. Thus, combinatorial blockade
of multiple metabolic pathways could be required to impose deficiency of key metabolites on malignant cells.
Pyrimidine nucleotides represent a class of metabolites that has been shown in numerous studies to be
essential for PDAC and a host of other malignancies. Importantly, there are several clinical grade inhibitors of
pyrimidine synthesis enzymes that have shown preclinical promise as anticancer agents. However, these
drugs have uniformly failed to show efficacy in clinical trials in which they were used as monotherapy against
various malignancies. One potential explanation for this is that there are two major pathways by which cells
generate nucleotides, termed the de novo and salvage pathways, and these inhibitors block the key de novo
pathway enzyme dihydroorotate dehydrogenase (DHODH), thus leaving the salvage pathway fully intact.
We’ve characterized the response of various PDAC cell lines to the DHODH inhibitor brequinar (BQ). We
found that some PDAC cell lines are highly resistant to BQ in cell viability assays compared to their more
sensitive counterparts. We then screened some 350 known kinase inhibitor compounds to probe for any that
could restore BQ sensitivity in our resistant PDAC cell lines, and this nominated the preclinical BTK inhibitor
CNX-774 as the strongest hit. Follow-up studies have shown that combined BQ/CNX-774 treatment leads to
profound cell viability loss and pyrimidine depletion, compared to either drug alone, in BQ-resistant PDAC
cells. Furthermore, we have strong evidence that CNX-774 is acting in an off-target manner to inhibit
pyrimidine salvage. Thus, the goal of this study is to uncover the mechanism by which CNX-774 is sensitizing
PDAC cells to BQ and determine if this drug combination is efficacious in our preclinical PDAC mouse models.
Our goal is to provide preclinical support for this metabolic combination therapy as a potential PDAC treatment.

Public health relevance
Project Narrative Pancreatic ductal adenocarcinoma (PDAC) is a devastating disease with a five-year survival rate of less than 10 percent, largely due to a lack of any effective therapy. Numerous studies have implicated pyrimidine nucleotide synthesis as a critical metabolic pathway for PDAC cell proliferation and viability; however, inhibitors of DHODH, a key enzyme in this pathway, have consistently failed to show efficacy as monotherapy in various cancer settings. Using a high throughput small molecule screen, we have identified a hit compound that can restore sensitivity to DHODH inhibition in PDAC cell lines that are inherently resistant; this project aims to uncover the mechanism by which this compound overcomes resistance to DHODH inhibition and test the in vivo efficacy of combination therapy, with the ultimate goal of nominating a novel PDAC treatment strategy.